Training of Surgeon Scientists in Basic and Translational Cancer Research

This application is the first competitive renewal for the T32 training program in the Department
of Surgery at the Albert Einstein College of Medicine. The goal of our program entitled -
“Training of Surgeon Scientists in Basic and Translational Cancer Research” - is to improve the
training of future surgeon cancer scientists. With the proposed continuation of this program, we
seek to provide a platform to train highly motivated surgical residents with an interest to pursue
a career in research and clinical surgery and who aspire to become surgeon scientists with a
focus on cancer. Our program is designed for surgical residents in the department of surgery to
spend two years dedicated to training in the conduct of basic and translational research. Based
on our success to date we seek to expand our initial program from one that focused on the
tumor microenvironment to a program that addresses more broadly the cancer biology research
programs in the Albert Einstein Cancer Center (AECC). Advances in the understanding of the
mechanisms controlling tumor initiation, progression, invasion and metastasis as well as the role
of the immune system in tumor growth inhibition are examples of the themes and coordination
of the programs in the AECC. By bringing together a team of mentors with a strong track record
of research accomplishments as well as sustained experience in training post-graduate fellows,
we plan to address an unmet need in the preparation of surgeons for a career in cancer
research. Our application includes outstanding faculty mentors and co-mentors representing 5
clinical departments and 4 basic science departments. The 14 faculty members include 12
senior mentors and 2 junior mentors. We have also included in our faculty 4 surgical faculty
advisors and two didactic faculty. The training program will consist of two years of laboratory
research, formal coursework and participation in relevant journal clubs and seminars. The
training will also include participation in the department of surgery’s annual research day and
attendance at departmental and professional conferences and relevant workshops. Successful
trainees will have submitted at least two abstracts to national meetings and at least one original
manuscript for peer review by the completion of the training program. The curriculum is
designed to prepare the trainee to pursue a career as a surgeon scientist. The program is
structured with a formal evaluation process in place to evaluate trainee, mentor and overall
program performance.

Public health relevance
Project Narrative: Given the important contributions made by investigator-surgeons in the past and the need to continue to address urgent questions in the future, there is a critical need to train surgeons to become scientists. The proposed program is designed for surgical residents to spend two years dedicated to training in the conduct of basic and translational research. The goal of our program is to provide a comprehensive curriculum for training surgical residents to become Surgeon Scientists in Basic and Translational Cancer Research.